Genetic Epidemiology of Sleep Apnea and Comorbidities in Biobanks

ABSTRACT
Sleep apnea (SA) and insomnia are the two most common sleep disorders, and both contribute individually and
jointly to the risk of cardiopulmonary, metabolic, and psychiatric diseases. Despite their high prevalence,
treatments for SA and insomnia remain suboptimal. SA and insomnia are thought to be comprised of distinct
subtypes, which remain poorly defined and may contribute to differing risks for health outcomes. Our goal is to
use machine learning to apply precise phenotyping to biobanks to identify the genetic bases of SA and
insomnia and discover SA and insomnia subtypes based on genetics and comorbidities in order to reduce
phenotype heterogeneity, guide patient stratification and aid in the discovery of more personalized treatments.
Our approach is to combine health care system biobank data with research polysomnography (PSG) to achieve
statistical power to discover genetic variants for SA and insomnia-related phenotypes and characterize their
associated clinical outcomes and endophenotypes (physiological mechanisms). We will use advanced natural
language processing (NLP) methods to substantially improve the accuracy of SA and insomnia phenotyping.
Our anticipated sample size will be >11-fold larger than prior genetic studies of SA, providing the necessary
statistical power for genetic discovery. Polygenic risk scores derived from our results can be used to quantify
sleep disorder risk, even among those without sleep phenotypes. Machine learning methods can identify
predictors of diagnosis-clustered patient groups contained within the medical record. Precision deeply-
phenotyped PSG data (eg hypoxic burden) can characterize endophenotypes at associated genetic loci using
genetic localization. We will derive advanced SA and insomnia phenotypes robust to demographic differences
across biobank sites, perform the largest genetic analysis of validated SA and insomnia phenotypes to date,
characterize novel loci, and study associations with clinical diagnosis data to improve patient classification in
three biobanks. We will explore sex-specific associations and validate lead genetic associations in two biobanks.
Our specific aims are: 1) to construct advanced SA and insomnia phenotying algorithms across diverse
demographic groups and sites; 2) to identify and characterize the genetic associations with SA and insomnia;
and 3) to identify and characterize distinct SA and insomnia patient subgroups based on related comorbidity
profiles. The proposed project has a goal of improving the treatment of heart, lung, blood, and sleep disorders
by potentially resolving disease heterogeneity, discovering novel genetic associations with sleep disorders, and
helping to clarify the overlap of SA and insomnia with cardiopulmonary, metabolic, and psychiatric disease.

Public health relevance
Sleep apnea and insomnia, the two most common sleep disorders, are thought to be comprised of distinct subtypes, which remain poorly defined and may contribute differently to the risk of cardiopulmonary, metabolic and psychiatric diseases. Current critical gaps in our understanding and treatment of SA and insomnia include reliable phenotyping of sufficient participants to discover additional genetic associations and identifying clinically diagnosed sleep apnea and insomnia subtypes that lead to increased risk of disease. This project will address these challenges by discovering novel genetic associations with sleep disorders, resolving disease heterogeneity, and helping to clarify the overlap of SA and insomnia with other diseases, with a goal of improving the treatment of heart, lung, blood, and sleep disorders.